Trans-Golgi Network Remodeling by Microbial Factors

PROJECT SUMMARY
Eukaryotic trans-Golgi network (TGN) has been extensively studied for its role as the major sorting
compartment and the center for terminal processing and modifications of newly synthesized proteins. While the
TGN is known for its dynamic nature associated with the constant flux of traffic, whether its structures can be
altered in microbe-eukaryote interactions and the subsequent consequences have remained elusive until
recently. Our previous study has discovered that multiple microbial factors (e.g., bacterial antibiotics nigericin
and gramicidin) are able to induce the disassembly of the TGN into vesicles. These dispersed TGN vesicles
then serve as a signaling platform for the assembly and activation of the NLRP3 inflammasome. NLRP3
pathway induces proinflammatory cytokines, and its hyperactivation has been closely associated with a wide
variety of human diseases, including autoimmune diseases, cancers, neurodegeneration, and metabolic
disorders. Importantly, these stimuli do not affect the closely associated cis- and medial-Golgi, indicating that it
is a tightly regulated reorganization event specifically targeting the TGN. Dissection of the detailed cellular and
molecular basis has been challenging because these stimuli are either small molecules or nonribosomal
peptides not encoded by genes. Recently, we have discovered two groups of microbial factors, i.e., pore-
forming toxins from bacteria and viroporins from viruses, as highly specific TGN-dispersing stimuli. The protein
nature of these stimuli has allowed us to easily track their translocation and genetically manipulate them to
study the effects on TGN remodeling. In addition, we found evidence that TGN remodeling is not only
important for inflammatory signaling, but also results in altered glycosylations. The ultimate goal of this MIRA
R35 proposal is to use these protein microbial factors as tools to study the detailed mechanisms and functions
of TGN remodeling. We will pursue three major questions: (1) What are the regions/motifs that are critical for
these stimuli to remodel the TGN? Our identification of novel TGN dispersion peptide motifs will greatly
facilitate future screening and identification of other TGN dispersion ligands in both microbes and eukaryotic
organisms. (2) What eukaryotic factors (e.g., TGN-localized GTPases and golgin family proteins) are involved
in TGN remodeling, and how conserved are their functions in other eukaryotic species such as yeast? (3) How
does TGN remodeling affect various eukaryotic cellular processes, including inflammatory signaling and
proteins modifications? Our proposed studies will help fill a critical knowledge gap on the mechanisms and
functions of TGN remodeling, as well as providing invaluable insights into the rational design of innovative
therapeutics to mitigate a wide range of human health problems.

Public health relevance
PROJECT NARRATIVE The organelle trans-Golgi network (TGN) serves as the major sorting compartment and the center for modifications of newly synthesized proteins. In this proposal we aim to dissect the conserved molecular and cellular mechanisms governing TGN remodeling by microbial factors and study the effects on eukaryotic cellular processes. Our discoveries will advance our understanding of TGN morphology maintenance and functions, which will lay the foundation for rational design of therapeutics for a wide variety of human diseases.